Molecular imaging of neuroinflammation in repetitive mild traumatic brain injury

Candidate: This Career Development Award (CDA2) describes research and training activities for Garth Terry,
MD, PhD, a psychiatrist and clinical neuroscientist in the Mental Illness Research, Education, and Clinical Center
at VA Puget Sound. His immediate career goal is to combine his established training in positron emission
tomography (PET) with newly acquired and ongoing training in the pathobiology and translational research of
mild traumatic brain injury (mTBI) and strengthen his training in group-wise neuroimage statistical analysis. Long-
term, he intends to establish an independent research program focused on using molecular neuroimaging to
enhance understanding and guide therapeutic development for neuropsychiatric disorders. Research:
Approximately 20% of service members returning from Iraq have experienced mTBI resulting in somatic,
cognitive, and behavioral symptoms leading to substantial disability and interference with job and family
relationships. Neuroinflammation has been implicated as an important contributor to the acute and chronic
effects of blast mTBI, and is associated with subsequent neurodegeneration. Both Veterans with history of blast-
related mTBI and a battlefield-relevant mouse model of repetitive blast mTBI demonstrate persistently elevated
IL-6. Furthermore, blast-exposed mice demonstrate persistent microglial pathology that is strikingly similar to the
neuropathology very recently identified in Veterans with blast-induced mTBI. This proposal specifically
addresses the need to understand if neuroinflammation is persistent following blast mTBI by imaging the
translocator protein kDa 18 (TSPO), a well-validated biomarker of neuroinflammation and a protein associated
with microglial activation. Using PET and the TSPO selective radioligand [18F]DPA-714, Dr. Terry will image mice
following blast mTBI (SA1), which provides a unique opportunity to control injury repetition and acuity, and to
characterize in vivo imaging results against ex vivo histopathological evidence of neuroinflammation and
neurodegeneration. Second, Dr. Terry will image TSPO using PET in Veterans with a history of blast mTBI (SA2)
to demonstrate the presence of chronic neuroinflammation. Resulting quantitative images of neuroinflammation
will be correlated against clinical measures and other biomarkers already collected from those Veterans. Career
Development Plan: This proposal serves Dr. Terry's short- and long-term goals by building his translational and
clinical research expertise in three critical areas: 1) translational application of PET neuroimaging, 2) translational
biomarker study and clinical assessments of blast mTBI, and 3) become an independent researcher-clinician
within VHA. Professional development activities include: routinely scheduled meetings with career mentors,
formal graduate coursework in statistics, neuroinflammation, and PET analysis; regular participation and
presentation for local seminars in mTBI and neuroimaging; and presentation of research at national scientific
conferences. By virtue of these goals, Dr. Terry will seek to clearly differentiate himself as an independent VA
investigator who is both unique from his mentors and complementary to their efforts in helping Veterans with
blast mTBI. Environment: Dr. Terry's training will be guided by an exceptionally multidisciplinary mentoring team
comprised of senior faculty who are experts in blast mTBI, human biomarker collection and study, mouse blast
mTBI pathobiology, and PET image research and analysis. His primary mentor, Dr. Peskind, is recognized as a
leader in the field of blast mTBI and has successfully mentored multiple trainees through CDA to independent
faculty position. Co-mentors Drs. Cook, Innis, and Mr. Muzi are fully-funded research faculty with expertise in
mouse models of disease, molecular biology, neuroinflammation, and PET neuroimaging and analysis. His
consultants include experts in in statistical analysis (Dr. Millard), PET imaging (Drs. Kinahan and Miyaoka), and
radiochemistry (Drs. Grierson and Kassiou). These investigators have established professional collaborations
with Dr. Terry and are invested in the success of the aims outlined herein.

Public health relevance
Blast related mild traumatic brain injury (mTBI) has been called the “signature injury” of Veterans who served in the recent conflicts in Iraq and Afghanistan. Though termed “mild,” repetitive blast exposures are common over the course of a military career and frequently result in persistent symptoms including cognitive and neuropsychiatric impairment, leading to a significant negative impact on the Veterans' quality of life. The aims of the current study are centered on understanding the role of inflammation in the brain following blast exposure as measured using molecular imaging. A mouse model of blast mTBI will be studied to interpret imaging findings directly with brain pathology, and Veterans with and without blast mTBI will be studied to interpret imaging results with other clinical research tests and clinical symptoms. Knowledge gained will provide translational evidence for neuroinflammation as an important process in understanding effects of blast mTBI, and provide the basis for which potential pharmacotherapies can be tested.